Role of perinatal testosterone in programming behavioral and astrocyte responses to early life chemotherapy

Abstract. Astrocytes play an essential role in early brain development, and sex differences in the maturation
of cortical astrocytes and their function have been described. While the role of astrocytes in early perinatal
brain development is a rapidly developing field, significant knowledge gaps remain. This application will test
the novel hypothesis that the perinatal testosterone surge in males alters astrocyte calcium signaling, which
renders males vulnerable to cognitive deficits induced by environmental exposures.
Long-term cognitive deficits are common amongst survivors of childhood acute lymphoblastic leukemia
(ALL). These deficits largely affect executive function (e.g., attention, impulse control) and memory. To
improve quality of life for leukemia survivors, there is a pressing need to better understand the underlying
neurobiological changes that link early life cancer+chemotherapy to cognitive deficits. To address this
question, we have developed a more translationally relevant mouse model that involves administration of a
leukemia cell line (L1210) and a cycle of chemotherapy (methotrexate, vincristine, leucovorin) between
postnatal day 19 (P19) and P33. We observe persistent deficits in learning, recognition memory and
executive function and have identified a link to glial dysregulation with chemotherapy exposure. Of note, we
observe a strong sex difference, such that female animals exposed to early life cancer+chemotherapy are
relatively resilient to executive function deficits as compared to males. Our preliminary data highlight a robust
transcriptional response in female astrocytes from the prefrontal cortex (PFC) that is absent in male
astrocytes. Pathway analyses identify genes related to Gq-coupled G protein-coupled receptor (GPCR)
signaling, calcium (Ca2+) mobilization and inhibitory gliotransmission as significantly changed in females.
Our findings of a strong sex difference in astrocyte responses to early life cancer+chemotherapy exposure
represent a robust readout with which to test our hypothesis. Manipulating the impact of the P1 testosterone
surge, combined with astrocyte specific gene expression and calcium imaging, and advanced operant
behavioral testing will provide a unique opportunity to dissect astrocytic contributions to cognitive
dysfunctions at molecular, cellular and functional levels of evaluation, in both normal development and in
response to challenge. Advancing knowledge around sex differences in astrocyte developmental biology has
broad implications for furthering understanding of neurodevelopmental disorders and/or responses to early
life adversity, both of which show sex biases.

Public health relevance
Narrative Survivors of childhood cancer that were treated with chemotherapy early in life often report problems with memory and executive function (attention, planning), and these effects can vary by sex. Experiments in the present application will determine whether early life exposure to sex hormones influences these sex differences by testing behavior and understanding effects on astrocytes in the brain.